Role of ER-mitochondria contact sites in Right Ventricular Fibrosis

Endoplasmic reticulum (ER)-mitochondrial (ER-Mito) microdomains play significant roles in the maintenance of
bioenergetics and basal cell functions via the exchange of lipids, Ca2+, and reactive oxygen species (ROS). Genetic
inhibition of mitofusin 2 (Mfn2), one of the key components of ER-Mito tethering, in cardiomyocytes (CMs) revealed
the importance of the microdomains between mitochondria and sarcoplasmic reticulum (SR), a differentiated form
of ER in muscle cells, for maintaining normal mitochondrial Ca2+ (mtCa2+) handling and bioenergetics in the heart.
However, it is still unclear which cellular signaling mechanism modulates Ca2+ handling at the ER/SR-Mito
microdomains in the heart during cardiac stress, and how this alters mtCa2+ and mitochondrial ROS (mROS) levels
in cardiac pathology. Our preliminary studies show that 1) Mfn2 is likely a c-Src substrate in mitochondria; 2) c-Src
can phosphorylate the C-terminal tail of Mfn2 at the outer mitochondrial membrane (OMM), a domain critical for
Mfn2 dimerization and redox sensing; and 3) c-Src-dependent tyrosine phosphorylation (P-Tyr) of Mfn2 decreases
the ER-Mito distance and facilitates ER-to-Mito Ca2+ transfer, followed by increases in mROS. Importantly, using a
preclinical rat model of pulmonary arterial hypertension (PAH) with right ventricular (RV) hypertrophy, fibrosis, and
failure, we found significant c-Src activation occurs only in cardiac fibroblasts (CFs) but not in CMs in the RV under
PAH, which subsequently causes a c-Src-dependent P-Tyr of Mfn2, decreased ER-Mito distance, increased mtCa2+
uptake and mROS, CF activation, and RV fibrosis. Similar preliminary results were obtained in RV tissue samples
from a pulmonary hypertension patient. Lastly, we found that mtCa2+ uptake via mtCa2+ uniporter (MCU) is required
for mROS elevation and subsequent activation of proliferative signaling in CFs. Based on these preliminary data, we
hypothesize that 1) c-Src-dependent P-Tyr of Mfn2 alters the ER-Mito tethering structure and causes increases in
mtCa2+ and mROS that promote CF activation, thereby acting as a molecular “switch” for the activation of RV-CFs in
PAH; and 2) CF-specific inhibition of c-Src at the OMM in vivo can be leveraged as a novel therapeutic strategy to
attenuate cardiac fibrosis in response to stress/injury such as PAH. The long-term goals of our study are to precisely
understand 1) the molecular basis of ER-Mito microdomain-mediated regulation of CF functions under pathological
conditions including PAH; and 2) develop novel therapeutic approaches targeting cardiac fibrosis-specific molecular
mechanisms.
In Aim 1, we
will establish Mfn2 as a novel c-Src substrate in mitochondria and assess the impact of
c-Src-dependent P-Tyr of Mfn2 on ER-mitochondria tethering, Ca2+ transport to mitochondria, mROS generation,
and downstream CF signaling activation using cellular systems. In Aim 2, we will specifically inhibit mitochondrial c-
Src only in the quiescent CFs by CF-specifically expressing OMM-targeted dominant-negative c-Src (mt-c-Src-DN)
in a preclinical rat PAH to evaluate the therapeutic potential of mitochondrial c-Src inhibition in vivo. The expected
outcomes of this project will provide fundamental new insights into the molecular interaction between ER-Mito
association, mtCa2+ uptake, and mROS and its functional relevance in CF activation and fibrosis.

Public health relevance
Project Narrative One of the common complications of pulmonary hypertension is right-sided heart failure associated with poor prognosis in patients. We have developed preliminary data showing that right-sided heart failure, in part, is mediated by excessive activation of cardiac fibroblasts induced by the specific enzyme named c-Src. This research will allow us to design a novel strategy for the management of right-sided heart failure during pulmonary hypertension.